BUILDING 436 - BACKUP POWER (WO#126555) AS RELATES TO REFURBISHMENT AND INFRASTRUCTURE IMPROVEMENTS WITHIN THE NCI AT FREDERICK CAMPUS

The objective of this work order is to put B436 on backup power. B436 houses the main steam condensate return for the
south boiler plant. During extended power outages the condensate pumps do not operate. Without condensate return to
the boiler plant there is insufficient treated water to operate the boilers. During a recent outage the boiler plant had to
operate on untreated water in order to keep the boilers operating. Operating with untreated water can damage the boiler
however loss of steam production is immediately detrimental to laboratory and animal building operations